COMT inhibition as a potential therapeutic target among individuals with comorbid Alcohol Use Disorder and Attention-Deficit/Hyperactivity Disorder

ABSTRACT
Alcohol Use Disorder (AUD) is a genetically influenced brain disease that is frequently comorbid with Attention-
Deficit/Hyperactivity Disorder (ADHD), a neurodevelopmental disorder that arises in childhood and persists into
adulthood in 30-45% of cases. The presence of one disorder significantly increases the likelihood of the other,
and individuals with comorbid AUD/ADHD are a challenging clinical population. Both disorders are characterized
by impairments in cognitive control, a process regulated in part by dopamine (DA) signaling in the prefrontal
cortex (PFC). Psychostimulants, the most commonly prescribed medications for ADHD, elevate PFC DA tone
and improve cognitive control. However, because psychostimulants also elevate striatal DA, they may potentiate
alcohol’s rewarding and stimulating effects, and reduce its sedating effects, among individuals with comorbid
AUD/ADHD. Non-stimulant medications have been tested in this population, but none has demonstrated effects
on both AUD and ADHD symptoms. Tolcapone (TOLC), a brain-penetrant catechol-O-methyltransferase
(COMT) inhibitor approved for the treatment of Parkinson’s disease, may more selectively potentiate cortical,
but not striatal, DA release, and has shown promise in improving cognitive control and reducing drinking in animal
models. TOLC’s effects may be influenced by a common single nucleotide polymorphism (SNP) in COMT that
regulates COMT efficacy. Individuals who carry the val allele of the COMT val158met SNP, which has been
associated with relatively higher COMT activity (and thus, lower PFC DA tone), may be more likely to benefit
from TOLC treatment. Our preliminary data indicate that TOLC reduces drinking among non-treatment-seeking
individuals with AUD, and does so to a greater extent among those with more ADHD symptoms and among
COMT val-allele carriers.
This project aims to evaluate TOLC as a pharmacogenetic probe for AUD/ADHD treatment, by testing its effects
on neuroimaging and laboratory-based AUD/ADHD measures and on drinking in the natural environment. A
group of unmedicated individuals with comorbid AUD/ADHD will be recruited, and a within-subjects, placebo-
controlled, double-blind design will be used to test TOLC and placebo effects on three sets of outcomes: 1) brain
activation associated with cognitive control, selective attention, and alcohol cue reactivity; 2) alcohol subjective
effects and risky decision-making after consumption of a standard drink in the lab; and 3) drinking over six days
in the natural environment. Additionally, an exploratory aim will evaluate whether COMT val158met genotype
moderates TOLC effects on any of these outcomes. Achievement of these aims will potentially advance brain-
penetrant COMT inhibitors as a new treatment option for individuals with comorbid AUD/ADHD.

Public health relevance
PROJECT NARRATIVE Alcohol Use Disorder (AUD) and Attention-Deficit/Hyperactivity Disorder (ADHD) are frequently comorbid, and both disorders are characterized by impairments in cognitive control, a process regulated by dopamine signaling in the prefrontal cortex (PFC). Our preliminary data suggest that tolcapone, a COMT inhibitor that may increase cortical dopamine release elicited during situations requiring cognitive control, reduces drinking, particularly among individuals with more ADHD symptoms. This project aims to advance the development of COMT inhibitors for comorbid AUD and ADHD by using a within-subjects crossover design to test the effects of tolcapone, relative to placebo, on laboratory-based measures associated with AUD and ADHD symptoms and on drinking in the natural environment.